Human milk metabolomics and microbe-host interactions associated with pediatric obesity

PROJECT SUMMARY/ABSTRACT
Pediatric obesity affects 1 in 3 children in the US and represents a public health crisis [1]. In utero exposure to
maternal obesity and caesarean section (C-section) are independently and jointly associated with offspring
obesity [2, 3]. Accumulating data suggests maternal obesity and C-section may seed an “obesogenic”
microbiome responsible for transmitting obesity risk from mother to child [4, 5]. Exclusive breastfeeding is
associated with protection against pediatric obesity [6]; however, the association between human milk
components and the microbiome that account for these observations are poorly characterized. Recent advances
in untargeted metabolomics provides a novel opportunity to comprehensively investigate how the human milk
metabolome in combination with microbe-host interactions are associated with infant adiposity during the first
year of life.
The Principal Investigator, Dr. Dominick J. Lemas, Ph.D. will use high-resolution mass spectrometry as a tool to
interrogate the human milk metabolome and infant microbiome in a longitudinal maternal-infant cohort of obese
and normal weight mothers that includes vaginally and cesarean section deliveries. The over-arching hypothesis
of this proposal is that the human milk metabolome will be associated with novel changes in the early infant
microbiome that alter risk for obesity and weight gain in the first year of life. In collaboration with a
multidisciplinary team of expert mentors (including primary mentor Dr. Christian Jobin and co-mentors Drs. Josef
Neu, Timothy Garrett, William Hogan, Janice Krieger), the primary goal of this K01 career development proposal
is for Dr. Lemas to develop expertise in high-resolution metabolomics, biomedical informatics and longitudinal
clinical microbiome studies. The University of Florida (UF) boasts an intellectually rich research environment that
will facilitate these goals. More specifically, longitudinal data collection will be completed at the NIH-funded UF
Clinical and Translational Science Institute and human milk and stool metabolomics analysis will be completed
at the NIH-funded UF Southeast Center for Integrated Metabolomics (SECIM). Finally, microbial sequencing will
be completed at the UF NextGeneration DNA Sequencing Core and high-throughput data analysis will be
completed at the UF Research Computing Center.
Specific Aim 1 will generate a data-driven recruitment plan using informant interviews and qualitative methods
to identify barriers and facilitators to successful participant recruitment and strategies. Specific Aim 2 will
characterize the role of the human milk metabolome on the development of the infant microbiome. Specific Aim
3 will identify how the human milk metabolome is associated with infant adiposity. The proposed research is
focused on the pathophysiology of infant growth and adiposity during early life and will inform subsequent studies
that seek to reduce the risk of pediatric obesity. The structured mentoring and training plan is designed to
facilitate Dr. Lemas's long-term goal of developing an independently-funded clinical and translational research
program focused characterizing the microbe-host interactions that mediate the protective role of breastfeeding
on pediatric obesity, consistent with the mission of the NIDDK.

Public health relevance
PROJECT NARRATIVE Pediatric obesity has more than doubled in children and tripled in adolescents over the past 30 years. Recent findings demonstrate that differences in energy harvesting bacteria promote obesity in the host and appear to be influenced by early life factors such as mode of delivery, maternal obesity, and breastfeeding. The goal of this proposal is to leverage untargeted metabolomics to investigate how human milk impacts the infant gut microbiome during the first 12-months of life and identify the microbe-host interactions that mediate the protective role of breastfeeding on infant adiposity. The results of this exploratory study will create an data-driven plan to recruit pregnant women into clinical microbiome studies and identify human milk compounds that stabilize a healthy infant microbiome and are associated with infant growth during a critical window of development.